FDA Laboratory Flexible Funding Model (LFFM)

FDA Laboratory Flexible Funding Model (LFFM) RFA-FD-25-007
Project Summary - Overall
Proposed Project Dates: July 2025 to June 2030
Colorado Department of Agriculture, Division of Laboratory Services- Biochemistry Laboratory
Overall: Project Summary
The Colorado Department of Agriculture (CDA) Biochemistry Laboratory (BCL) is seeking funding under FDA
funding opportunity RFA-25-007, Laboratory Flexible Funding Model (LFFM) FDA-FD-25-007.The Colorado
Department of Agriculture is committed to working with the FDA to enhance the capacity and capabilities of
state human and animal food testing laboratories to support the overall goal of an integrated food safety
system (IFSS). The CDA supports the goal of the Microbiology Analytical Tracks A1, A3, and A8 and a
coordinated sampling program to improve food testing surveillance programs through the microbiological
analysis of human and animal food products, including capability and capacity. Our Research Plan for these
three Microbiology Analytical Tracks and associated sampling projects establishes that the CDA Biochemistry
Laboratory (CDA-BCL) meets the eligibility requirements for this funding opportunity. Furthermore, our
research plan demonstrates that the CDA-BCL is competent and currently has the capability to achieve the
program requirements and goals outlined in the funding opportunity, including the proper laboratory facilities
and equipment, credentialed sampling program, organizational structure, personnel, management system,
food testing capabilities, and laboratory quality management system. Through overall funding requested, the
CDA-BCL will:
● Conduct 250 microbiological analyses of human food samples through A1 - Microbiology Human Food
Product Testing
● Conduct 100 microbiological analyses of animal food products through A3 - Microbiology Animal Food
Product Testing.
● Expand our laboratory's capabilities by participating in analytical track A8: Microbiology
Capability/Capacity Development. CDA-BCL proposes to implement the Loop-Mediated Isothermal
Amplification (LAMP) protocol as a primary Salmonella screening method and to integrate the FDA
BAM chapter 7 to detect and isolate Campylobacter.

Public health relevance
FDA Laboratory Flexible Funding Model (LFFM) RFA-FD-25-007 Project Narrative - Overall Proposed Project Dates: July 2025 to June 2030 Colorado Department of Agriculture, Division of Laboratory Services- Biochemistry Laboratory Overall: Project Narrative Public Health Relevance The Colorado Department of Agriculture's Biochemistry Laboratory will collaborate with the FDA to ensure the safety of the human and animal food supply and to improve public health through a nationally integrated food safety system. Our efforts will support the goal of "enhancing the capacity and capability of state human and animal food testing laboratories to contribute to an integrated food safety system,” specifically by providing testing and reliable data to strengthen collaboration among the FDA, state, and local partners.